THE ROLE OF BASEMENT MEMBRANE PROTEINS IN TROPHOBLAST IMPLANTATION SITES

We will study the synthesis of basement membrane proteins, laminin and type Iv collagen as well as the role of enzymes such as collagenase IV in trophoblastic implantation sites.